Mechanisms of Dopamine Transmission in the VTA

DESCRIPTION (provided by applicant): Alterations in dopamine transmission occur during drug abuse and addiction. To understand these changes, it is necessary to first understand the basic physiology that underlies dopamine transmission. The aim of this Pathway to Independence Award (K99/ROO) proposal is to investigate the mechanisms of dopamine transmission while providing the candidate (Dr Christopher Ford) with the necessary mentored training in electrophysiological and electrochemical techniques. The applicant's long-term career goal is to develop into an independent investigator studying the molecular and cellular basis of addiction. To meet this goal, this proposal is designed to (1) provide the candidate with the technical and theoretical training required to determine how dopamine mediates transmission in the ventral tegmental area (VTA), and (2) provide the candidate with the career-development training required to establish his own independent research career as an R01-funded assistant professor. The career development plan involves mentorship by a highly established drug abuse researcher (Dr John T Williams) in electrophysiological and electrochemical techniques. Combining these two tools to examine dopamine transmission has not been performed to date and as such has the potential to provide a unique opportunity for the candidate to initiate an independent career. The central aim of this proposal is to determine the relationship between extracellular dopamine and its physiological consequences. The objective during the mentored phase will be to determine the mechanisms regulating dopamine transmission. The hypothesis to be tested is that dopamine mediates transmission in the VTA in a tightly regulated, synaptic manner. The objective during the independent phase will be to define the concentration and duration of dopamine mediating transmission. The hypothesis being that transient, high concentrations of dopamine mediate transmission. A lack of knowledge of the basic mechanisms of dopamine transmission has hindered progress towards determining how transmission becomes dysregulated during the course of drug addiction. Thus this work has the potential to identity and direct new strategies to treat drug abuse and addiction. PUBLIC HEALTH RELEVANCE: Determining the mechanisms by which dopamine mediates transmission is a key first step to providing the framework necessary for understanding how this system is altered as a result of chronic drug use. A better understanding of the events linking dopamine release to its physiological actions will be significant as it has the potential to direct new strategies for the treatment of drug abuse and addiction.